Molecular Repair of Diabetic Mesenchymal Stem Cells (dMSC) for Peripheral Arterial Disease

Background and Innovation: Diabetes and ischemia lead to loss of neuromotor connections resulting in
disability. Diabetic Veterans with PAD have significant therapeutic needs that are often incompletely addressed
due to limitations in our understanding and therapeutic options. Functional recovery of ischemic muscle is the
goal of this proposal. Innovative aspects of our approach include: 1) determining mechanistically the epigenetic
opportunities that exist in diabetic mesenchymal stem cells, which may be useful in a number of pathologies
affecting Veterans with diabetes; 2) defining the role of macrophage subsets on re-innervation of new muscle,
how this is disrupted by diabetic conditions, and then testing how cell therapy may be able to direct the desired
macrophage mediators to more rapidly and/or more completely re-innervation new muscle.
Significance and impact to Veteran Healthcare: Diabetes and peripheral arterial disease disproportionately
affect our nation’s Veterans. Diabetic patients have limited collateralization and regenerative capacity in their
tissues. Diabetic patients with peripheral arterial disease also have severe ischemic myopathy and de-
innervation that impacts their functional ability to walk. Regenerative cell-based therapies may enable a full step
forward in establishing functional recovery of the vascular supply and skeletal muscle, including reformation of
the neuromotor junctions necessary for functional recovery. We have identified a unique intracellular signaling
defect in diabetic mesenchymal stem cells that is epigenetically modifiable, enabling autologous cell therapy in
diabetic patients. This proposal will test the epigenetic regulators of these favorable changes in diabetic
mesenchymal stem cells, the role of the innate immune cells in the reformation of neuromotor junctions, and
then test the capacity of diabetic mesenchymal stem cells to empower functional regeneration of muscle under
diabetic conditions using relevant in vitro and in vivo models.
Path to translation/implementation: Promising results from this work will provide a number of translational
opportunities for Veterans with diabetes, including the development of epigenetic therapeutics for diabetic
mesenchymal stem cells and patients, development/testing of novel therapeutics for ischemic myopathy/re-
innervation of diabetic muscle, and the role of immunomodulatory therapies in large animal and first in Veteran
testing.

Public health relevance
Skeletal muscles are profoundly affected by diabetes and peripheral arterial disease. The increasing incidence of diabetes and peripheral arterial disease make ischemic myopathy of leg muscles a major clinical problem for Veterans. This proposal seeks to build upon our prior successes with rejuvenated mesenchymal stem cells to improve functional skeletal muscle regeneration under ischemic and diabetic conditions.